Short-Term Research Training at New England College of Optometry

Abstract
The New England College of Optometry (NECO), founded in 1894, is the oldest optometry school in the
United States. It is dedicated to advancing optometric knowledge through research and education. NECO's
Myopia Research Center has played a pivotal role in signiﬁcant research eﬀorts, including the landmark
17-year COMET clinical trial. Over the past ﬁve years, NECO has secured over $7.5 million in research grants,
primarily from the NIH/NEI. The long-standing T35 training program at NECO introduces optometry students
to research, aiming to cultivate clinician-scientists who bridge the gap between clinical practice and scientiﬁc
research. This program provides students with hands-on experience in cutting-edge research methodologies,
promoting the development of critical thinking and innovative problem-solving skills essential for translating
basic research ﬁndings into clinical practice. The T35 program at NECO seeks to renew its funding to continue
its mission of developing clinician-scientists by educating trainees in the fundamental skills necessary for
planning and executing basic, translational, and clinical research projects. The program provides
comprehensive research training under the mentorship of experienced faculty, encourages trainees to pursue
research careers in optometry, and demonstrates how basic research ﬁndings can be eﬀectively translated
into clinical practice. NECO collaborates with several prestigious institutions, including the Schepens Eye
Research Institute, Northeastern University, and Boston Children’s Hospital, creating a rich, multidisciplinary
research environment. The program involves 21 mentors from NECO and aﬃliated institutions, oﬀering a
diverse range of research opportunities in vision science. These mentors guide trainees through every facet of
the research process, from reviewing literature and designing experiments to collecting data, performing
statistical analyses, and presenting ﬁndings. Dr. Panorgias, an experienced researcher with a strong
background in vision science, leads the program. He oversees the program's structure and trainee admission,
ensuring that students receive comprehensive training and mentorship. NECO's commitment to research is
also evident in its robust support for faculty research activities, including substantial start-up packages for
new hires and protected scholarship time for faculty members. The T35 program not only enriches trainees'
educational experiences but also contributes to the broader mission of advancing eye care through research
and innovation. By fostering the development of clinician-scientists, NECO aims to lead advancements in
optometry and vision science, addressing complex health challenges with interdisciplinary approaches. This
renewal application for the T35 program seeks to ensure the continued development of optometry students
into clinician-scientists, thus enhancing the quality of eye care through research and innovation.

Public health relevance
Narrative Training clinician-scientists is crucial to public health as it advances fundamental knowledge in vision science, leading to the development of new treatments and diagnostic methods for ocular diseases. By fostering clinician-scientists who can translate research ﬁndings into clinical practice, the program aims to enhance eye health, reduce vision-related disabilities, and improve quality of life. In the long term, these eﬀorts will contribute to better preventative care and innovative therapeutic strategies, ultimately enhancing public health outcomes.